Prospective changes in patient-reported and objective functioning following reduction of cannabis use

PROJECT SUMMARY/ABSTRACT
Rates of cannabis use and cannabis use disorder (CUD) among adults in the United States are increasing
and the perception of harm associated with cannabis use continues to decline. Further, motivation to completely
abstain from cannabis is low. Harm reduction strategies and their benefits have strong empirical support across
other substances (alcohol, opioids, and stimulants) with validation of non-abstinence endpoints as indicators of
treatment success. While preliminary evidence–some from our group—suggests that cannabis harm reduction
may yield benefit in certain domains, a comprehensive, prospective, and rigorous assessment of the potential
benefits of reduced cannabis consumption has not yet been conducted. The accumulating evidence base to
suggest benefits to cannabis use reduction is promising; however, this literature is limited in four key ways: 1)
knowledge has largely been derived from secondary analysis of trials that were not designed to evaluate the
benefits of harm reduction and that did not measure cannabis use and reduction in standard delta-9-
tetrahydrocannabinol (THC) units, 2) thresholds of meaningful cannabis reduction are lacking, 3) there are no
consensus outcomes to demonstrate cannabis use reduction results in meaningful improvement, and 4) studies
have failed to comprehensively capture patient-reported and objective improvement in functioning. The current
proposal seeks to address an important gap in knowledge and is informed by our group’s data-driven metrics of
clinically significant cannabis use reduction.
We propose an 8-week cannabis use reduction trial for adults (ages 18+; N=176) with CUD. All participants
will receive comprehensive CUD treatment, inclusive of cognitive behavioral therapy, brief motivational
interviewing, and incentives for reduction. Specific aims are to assess: 1) associations between cannabis
reduction and end-of-treatment cannabis-related problems, 2) improvements in objective measures of sleep and
cognitive performance based on degree on cannabis use reduction, and 3) quality of life, CUD criteria count and
severity, and other psychosocial improvements based on degree of cannabis use reduction. The overarching
hypothesis is that participants reducing cannabis use will show significant, dose-dependent improvement across
patient-reported and objective outcomes. In an exploratory aim, we also propose to capture patients’ perceptions
of their areas of greatest improvement, as well as successful reduction strategies.
Despite strong empirical support for harm reduction for other substances, it is currently unknown if cannabis
harm reduction approaches will produce beneficial outcomes. The proposed study will fill a critical gap, as it is
specifically designed to recruit those interested in cannabis reduction for a reduction-focused trial and will assess
a variety of patient-reported and objective outcomes. Results will have the potential to impact CUD research and
treatment by promoting a shift toward alternative, non-abstinence outcomes of treatment success.

Public health relevance
PROJECT NARRATIVE Rates of cannabis use and cannabis use disorder (CUD) among adults in the United States are increasing and there is growing acknowledgement of the importance of non-abstinence based endpoints in research and treatment to minimize the adverse impact of regular cannabis use. While preliminary evidence suggests that cannabis use reduction may yield benefit in certain domains, a comprehensive, prospective, and rigorous assessment of the potential benefits of reduced cannabis consumption has not yet been conducted. This study proposes the first prospective examination of the benefits of cannabis use reduction on a wide array of patient- reported and objectively measured outcomes among adults using cannabis regularly.